Dissecting Neural Circuits Involved in Musculoskeletal Pain

There is an unmet need to identify therapeutic approaches to alleviate pain associated with inflammatory
and osteoarthritic (OA) joint conditions. Joint pain affects over 50 million adults in the United States which is
roughly 25% of the population. Severe arthritis is a leading cause of chronic pain, disability and reduced
quality of life. Current treatment strategies for OA focus on improving function through weight loss and
exercise and providing symptom relief with pharmacological analgesics such as acetaminophen, nonsteroidal
anti-inflammatory drugs (NSAIDs) and opioids. Disease modifying agents for treating OA are limited so chronic
administration of these analgesics is the mainstay for treatment. However, adverse outcomes related to long
term use of NSAIDs (gastrointestinal bleeding) and opioids (i.e. abuse liability) increase the need for
identification of alternative analgesics and approaches to alleviate joint pain.
A critical barrier to progress in the field is lack of knowledge regarding the distribution of subsets of sensory
neurons in bone and joints and how this changes under arthritic conditions. This is in part due to difficulty
measuring patterns of innervation within thin sections of decalcified skeletal tissue. In recent years, methods
have been developed to clear large sections of tissue in the brain to better visualize neural circuits; however,
these approaches have not been applied extensively for examining distribution and topography of molecularly
defined sensory neuron subsets within skeletal tissue. In the current proposal, we will refine methods for
clearing, imaging and 3D analysis of molecularly defined subsets of nerve fibers within mouse bone and joints.
We will also develop pharmacological and optogenetic approaches using Flp/Cre driver mice and viral vectors
to determine the contribution of 5-HT3R+ afferents to spontaneous and movement evoked pain behaviors
associated with inflammatory and post-traumatic osteoarthritis.
The proposed studies will provide an unprecedented view of the density, topography and distribution of
subsets of sensory neurons within the normal and arthritic knee joint. Importantly, these studies will lay the
groundwork for future studies examining the functional contribution of subsets of sensory neurons in driving pain
related behaviors and disease pathogenesis in several musculoskeletal pain conditions.
1

Public health relevance
Narrative Despite the clinical significance of arthritic joint pain, our understanding of mechanisms that drive this persistent pain state are incomplete. In the current project, we will apply advanced methods for clearing, imaging and 3D analysis of sensory innervation within intact normal and arthritic knee joint of male and female mice. We will also develop optogenetic and selective pharmacological approaches to examine the contribution of molecularly defined subsets (5-HT3R+) of sensory neurons in spontaneous and movement evoked pain due to inflammatory and post-traumatic arthritis.